Administrative Core

Project Summary
The central theme of the Indiana University (IU) Cooperative Center of Excellence in Hematology (CCEH) is
the regulation of nonmalignant human and murine hematopoiesis at the level of hematopoietic stem (HSC) and
progenitor (HPC) cells, cytokines, chemokines, growth factors, and the microenvironment. This was the focus
of the IU-CCEH during the last funding period. We continue to pursue this hefty goal, as we realize that there is
still much more that needs to be rigorously defined in these areas. The goals of the investigations of members
of this center are to leverage different components of the hematopoietic system to improve and advance
clinical utility and efficacy of HSC/HPC-based therapies. Treatment of inherited disorders of bone marrow-
derived cells can be achieved by both cellular and genetic approaches that are applicable to many diseases
and disorders. However, successful application of these modalities requires a deeper understanding of the
cellular, molecular, biochemical HSC and HPC regulation and hematopoietic parameters impacting their
efficient use in transplantation such as homing, cell cycle regulation, self-renewal, epigenetics, and the status
of the hematopoietic niche. The proposed IU-CCEH brings together the active participation of 25 members who
are well funded by the NIH, DoD, or the VA. These investigators are highly interactive with diverse and
complementary expertise in hematopoiesis and HSC biology and other disciplines that impact directly or
indirectly on multiple components of the hematopoietic system. The IU-CCEH proposes the establishment of 3
biomedical research cores focused on bringing state-of-the-art technologies that advance the work of the
members of this center, other similar CCEH centers across the country, and qualified investigators nationwide
who do not belong to any NIDDK-funded CCEH. In addition, the IU-CCEH will have an Enrichment Program
Core tasked with establishing training programs for young and future scientists interested in nonmalignant
hematology research. The specific aims of the IU-CCEH are: 1) Establish, operate, and administer three vital
biomedical cores providing essential services to investigators at the IUSM and others outside the IUSM who
are involved in the highest quality nonmalignant basic and clinical research in HSC/HPC biology. 2) Establish,
operate and administer an Enrichment Program to support, promote and enhance the research of young
investigators in the area of nonmalignant HSC regulation and clinical utility of HSC. 3) Actively participate in
the implementation of a Partner Pilot and Feasibility funding mechanism organized by all NIDDK-sponsored
CCEH centers across the U.S.A. 4) Coordinate fiscal management of the cores of the proposed application. 5)
Work closely and cooperate with other CCEH centers nationwide to adopt and implement policies, funding
mechanisms, and opportunities via our proposed cores targeting young as well as established investigators to
promote and sponsor diverse areas of nonmalignant hematology research at the highest levels.

Public health relevance
Narrative N/A